THERMODYNAMICS OF FOLDING OF E COLI DIHYDROFOLATE REDUCTASE

The reversible thermal unfolding of wild type and mutant dihydrofolate reductase (DHFR) from E. coli has been previously studied by optical spectroscopy. This information indicated the presence of molten globule type intermediates as well as irreversible type melting. In order to further explore these results, a series of DSC experiments at a number of different pHs were conducted using the C85S/C152E DHFR mutant. The lack of the disulfide bonds, that are present in the wild-type, greatly increased the reversibility of the thermal denaturation. It was also found that the protein achieves maximum stability at pH 7.0 with destabilization occurring above and below this value. Presently, experiments are being conducted at high salt concentrations in an attempt to further stabilize possible intermediates. Circular dichroism (CD) at reduced concentrations will also be performed to investigate the concentration dependent behavior found in the DSC results.